HIV self-testing with online supervision for Vietnamese MSM

PROJECT SUMMARY/ABSTRACT
There is a concentrated HIV epidemic among young men who have sex with men in Vietnam
where HIV incidence was reported to be 5.8 per 100 person-years, one of the highest
incidences in the region. Regular (at least annual) HIV testing of YMSM of unknown or HIV
negative serostatus is critical for timely linkage to HIV prevention services, such as risk
reduction counseling and HIV chemoprophylaxis. Among YMSM unaware of an existing or
new HIV infection, timely identification is necessary to increase linkage and initiation of
antiretroviral treatment and care to improve disease outlook and prevent onward HIV
transmission. However, structural, logistical and psychosocial barriers limit the uptake and
retention of Vietnamese MSM in regular HIV testing, hindering the rollout of much needed
HIV prevention and treatment services targeting this population. This study proposes the use
of online HIV testing (OHT) as an alternative HIV testing modality to increase engagement,
retention and linkage of YMSM in HIV prevention, treatment and care services. The specific
aims of this research proposal are 1) To identify potential barriers and facilitators to uptake
of OHT among YMSM; 2) to develop an empirical profile of barriers and facilitators to HIV
testing among YMSM, including an estimate of the proportion of YMSM likely to participate
in an OHT intervention; and 3) To conduct a preliminary assessment of the OHT
intervention, including introduction of a new HIV rapid diagnostic antibody/antigen-based
self-testing with an HIV counselor through video conferencing, and “real time” self-collected
dried blood spot (DBS) technology with centralized HIV DNA testing. Results of rapid testing
will be read- and of centralized testing will be delivered by video conference, followed by
discussion, post-test counseling and linkage to care and treatment, in a 12-month pilot
study. Particularly, logistical issues, concerns over rapid HIV self-testing, DBS self-collection
and laboratory testing, reading or reporting of results by video conferencing will be
assessed, as well as how OHT may help to overcome some of the existing barriers to
venue-based HIV testing. Using new HIV diagnostic and online technologies, OHT may be a
promising strategy to increase engagement, retention and linkage to HIV prevention,
treatment and care services among Vietnamese YMSM.

Public health relevance
PROJECT NARRATIVE There is an HIV crisis among young men who have sex with men in Vietnam where 1 in 5 are positive. Regular HIV testing is critical for timely linkage to HIV prevention services, such as risk reduction counseling and HIV chemoprophylaxis. This feasibility study proposes the use of HIV self-testing with online support as an alternative HIV testing modality to increase engagement, retention and linkage of YMSM in HIV prevention, treatment and care services.